Core B: Proteomics Core.

Project Summary
Many deadly cancers show mutations in a pathway driven by forms of cyclin D, Cdk4 or Cdk6, their inhibitory
proteins, the Rb retinoblastoma protein, and the E2F transcription factors. These include breast cancer,
melanoma, head and neck cancer, esophageal and pituitary cancers. We know that Rb suppresses E2F
transcription factors to control genes critical for cell proliferation, but Rb also has transcription-independent
activities that impact cell division and survival. Considerable interest is driven by the clinical efficacy of the
cyclin D/Cdk4 inhibitor palbociclib, suggesting that additional components of this pathway may be targets of the
inhibitor, or that new targets may reside within the pathway. Despite proteomic work identifying proteins that
associate with pathway components, the key molecular effectors and regulators of the Rb pathway and protein
post-translational modifications (PTMs) that regulate these factors remain unclear. Here we will focus first on
systematically identifying (1) the proteins, PTMs, and signal dependencies observed during G1/S progression;
(2) identifying which pathway components respond to Palbociclib by shotgun and phosphoproteomics; (3)
defining nuclear and cytoplasmic regulated complexes for Cyclin D-Cdk4/6 and Rb/E2F components; (4)
building protein interaction networks to link PTMs to protein interactions and activity; (5) determining the
specificity of interactions among paralogs of the Cdk4/6, Cyclin D1/2/3, Rb and E2F components; and (6)
identifying TCGA cancer lesions found within components of this pathway. These measurements and
perturbations performed by the Proteomics Core will be assembled into a network of PTMs and protein-protein
interactions (PPIs), driving new hypotheses for this critical cancer pathway.

Public health relevance
Project narrative The Proteomics Core run by Dr. Peter Jackson will facilitate the analysis of protein-protein interactions, post- translational modifications, and the identification and analysis of protein complexes to comprehensively understand all paralogs of Cdk4/6, cyclin D1-3, Rb and E2Fs. By combining affinity-purification of wild type and mutant proteins, including mutations in protein modifications and patient-derived mutations, coupled to mass spectrometry, plus shotgun and phosphoproteomics techniques, and using a new ultrasensitive timsTOF mass spectrometer, this core will deliver state of the art data and analyses of the core proteins analyzed in all three projects of this grant. The high throughput of this facility and rapid data communication will be an important hypothesis generating function favoring new understanding of the molecular drivers of cancer linked to the cyclin D/CDK4/6 complex and those highly responsive to the clinically important cancer therapeutic palbociclib, a CDK4 inhibitor.